Circuitry and function of ventral striatum subregions

PROJECT SUMMARY
Substance abuse and misuse pose significant costs to society and represent a global disease burden.
Relapse after a period of drug-free abstinence is one of the most profoundly debilitating aspects of addiction,
occurring in 40–80% of individuals. Understanding the neurobiological mechanisms of drug taking and relapse
will ultimately lead to better therapeutic interventions. The ventral striatum is a network of brain structures
implicated in compulsive drug-seeking and includes the ventral pallidum, nucleus accumbens (NAc), and
olfactory tubercle (OT). The OT, like the NAc, is a site of massive innervation of dopaminergic neuron
terminals from the ventral tegmental area in the midbrain. Rodents self-administer psychoactive substances
and electrical current into the OT, and more readily administer cocaine into the OT than even NAc. Further,
our lab has uncovered that the activity of OT neurons robustly reflects reward-guided behaviors and rewards.
Despite this evidence pointing towards a role for the OT in mediating reinforcement, little is known about the
OT, and at present, the OT is not included in mainstream models of the reward system. The short-term goal
of this project is to build off both our published and unpublished studies positioning the OT in the reward
circuitry to determine mechanisms whereby the OT exerts control over cocaine seeking and taking. Our overall
hypothesis is that there is a functional organization amongst ventral striatum subregions which influences
drug seeking. There are three aims to be executed by our collaborative team of experts in addiction
neurobiology, synaptic neurobiology, and in vivo physiology and behavior. First, we will use brain slice
recordings to determine the circuitry which connects the OT with the ventral tegmental area and ventral
striatum structures. Second, we will use in vivo physiological methods to demonstrate manners whereby OT
neurons, including OT medium spiny neurons, represent drug seeking. Finally, we will employ cell-specific
optogenetic methods to determine the regulation of reinforcement and drug-seeking by OT neurons. The
results of this project will answer long-standing questions about the fundamental circuitry of the OT and its
significance in the context of motivated behavior and drug-seeking. Together this project will contribute to our
long-term goal of generating a more complete model of the brain’s reward system.

Public health relevance
PROJECT NARRATIVE Relapse to cocaine addiction is a clinical problem and the use of rodent models of cocaine seeking informs the understanding of the brain regions involved in this behavior. The results of the proposed work will provide mechanistic information into the role of a previously overlooked region – the olfactory tubercle in the ventral striatum. This research is relevant to the missions of NIH and NIDA because it seeks to understand the brain mechanisms of psychoactive drug effects and may lead to new treatments to reduce relapse.